Multi-Ancestry Genetic Analysis of Type 1 Diabetes and Related Conditions

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is a highly prevalent disorder affecting over 8 million individuals worldwide. T1D causes
significant morbidity and mortality, including acute complications such as diabetic ketoacidosis as well as
chronic complications such as nephropathy, neuropathy, retinopathy, and cardiovascular disease. Developing a
deeper understanding of T1D risk factors is critical to reduce diabetes-related complications, to identify
individuals at high risk for T1D, and potentially to delay or to prevent the onset of T1D.
Because T1D is characterized by autoimmune destruction of insulin-producing beta cells, T1D risk is strongly
influenced by genetic variants related to immune function. Genetic risk for T1D can be quantified with a
polygenic score, which integrates the disease risk of causal variants from across the genome. Current
polygenic scores have demonstrated excellent predictive power to identify those individuals most likely to
develop T1D. However, most existing scores were developed and validated in individuals with European
genetic ancestry, and their predictive power declines when applied to other populations.
In this proposal, we will develop a multi-ancestry T1D polygenic score that integrates genetic variants from
diverse ancestral populations. We will apply this score to predict risk for T1D as well as for certain atypical
immune-mediated forms of diabetes, which may share genetic risk factors with T1D. Additionally, we will apply
computational methods that analyze T1D genetic risk factors to identify genetic subtypes of T1D.
The proposed project will provide advanced training in computational biology and statistical genetics. The
research setting represents an ideal environment for junior investigators, combining the world-class clinical
expertise of Massachusetts General Hospital with the innovative computational resources of the Broad Institute.
This project will provide a foundation for the candidate to apply for independent research funding and ultimately
to establish a career as a physician scientist.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D), which is characterized by the loss of insulin-producing beta cells, is a chronic condition that carries significant global morbidity and mortality. While multiple genetic risk factors have been implicated in T1D pathophysiology, T1D genetic risk among non-European populations is less well understood. In this proposal, we will assemble genomic data from diverse ancestral populations to improve prediction of T1D risk, to identify genetic subtypes of T1D, and to refine classification of atypical immune-mediated forms of diabetes.